CONTROLLED TRIAL OF 4-ASA IN SMALL BOWEL CROHN'S DISEASE

The aims of this study are to assess the efficacy and safety of 4- aminosalicylic acid in subjects with active Crohn's disease of the small bowel in a placebo controlled trial.